Deep South KUH Premier Research and Inter-disciplinary Mentored Education (PRIME) Admin Core

PROJECT SUMMARY
The Deep South of the United States has a disproportionate burden of kidney, urology and non-malignant
hematology (KUH) diseases as well as disparities in health outcomes related to these conditions. To reduce or
eliminate these disparities, it is imperative to grow the scientific workforce of investigators who can generate
new insights into mechanisms underlying KUH diseases and develop interventions for their prevention,
treatment and cure. The mission of the Deep South KUH Premier Research and Inter-disciplinary
Mentored Education (PRIME) program is to develop a modern workforce of investigators in the Deep South
who have the training, skills and drive necessary to advance KUH health through science and medicine. We
will do so by leveraging the distinct research strengths and complementary training assets at Augusta
University, Tulane University, and the University of Alabama at Birmingham to form a cohesive training
network. These institutions have long-standing research partnerships such as the CTSA-funded Center for
Clinical and Translational Science Partner Network and a track record of collaborations that have made
seminal contributions to KUH science. The Administrative Core (AC) will provide oversight of the entire
program and amalgamate the other cores (Network, Professional Development, and TL1) to facilitate the
development of future KUH scientists. The AC will be the center point of the organizational structure and
governance of the entire program, leveraging the collaborative spirit and established relationships between
KUH scientists at the three institutions to form a cohesive training network. In this capacity, the AC will deliver
timely and efficient communication regarding overall program activities, initiatives, and proposed changes;
assure quality of the network by development and assessment of milestones based on specific metrics; and
solicit input from internal and external sources to enhance programmatic evaluation. A full-time Program
Manager will facilitate communication between the aforementioned entities and individuals; be responsible for
coordinating and scheduling meetings across all cores; collate evaluations; and manage budgetary data. This
will allow us to accomplish the following Aims: (1) integrate KUH-focused training mechanisms throughout the
Deep South into a new, unified KUH training ecosystem; (2) establish an evaluation program for the Deep
South KUH PRIME and all of its Cores, trainees and mentors, including reviews from internal and external
evaluation boards; (3) assure that diversity, equity and inclusion are key components of the overall network;
and (4) organize a yearly “Building the KUH community” symposium, which will provide a platform for trainees
to present their investigative findings and grow a fertile networking environment. Our multiple PI team has an
exemplary record in leading collaborative research programs and training KUH scholars ensuring that we will
accomplish our overall vision to create and nurture a community of scholars that is diverse, inter-disciplinary,
inter-connected, and well-equipped with skills to transform and advance scientific discovery.